Diabetes and Obesity Training Grant

Contact PD/PI: WEK, RONALD C
PROJECT SUMMARY
The Indiana University Diabetes and Obesity Training Program began in 1999 and has been funded by the
NIDDK for twenty years, currently at the level of two pre-doctoral and two post-doctoral trainees per year. In
addition, the program supports four medical students each summer who receive short-term training as part of
the NIDDK Summer Medical Student Research Program. The goal of the Diabetes and Obesity Training Program
is to provide excellent training in research relevant to diabetes, metabolism, and obesity to researchers at an
early stage of their careers. This training program is led by two dedicated Co-Directors, Drs. R. Wek and C.
Evans-Molina, who are assisted by outstanding Executive and Selection Committees, with oversight and
guidance provided by an Advisory Committee of key internal advisors and world-renowned external advisors.
Twenty-five faculty preceptors from ten departments and five degree granting programs participate as mentors
in the program. This group of faculty has a strong training and research record and receives a total of $22.2M in
annual direct research funding, with $5.3M of this support coming from NIDDK R- and K-grants and $0.87M from
the JDRF and the ADA. In addition, this outstanding group of faculty has obtained $1.8M of U and P grant support
from the NIDDK. Pre-doctoral students in the training program complete a Minor in Diabetes and Obesity, which
includes a 2 credit Diabetes and Obesity course. Post-doctoral fellows also take this course. Students and post-
doctoral fellows attend and present their research at the Center for Diabetes and Metabolic Diseases seminar
series and at national meetings such as the ADA Scientific Sessions. To ensure contemporary and well-rounded
training, scholars complete courses on the responsible conduct of research and rigor and reproducibility in
research. Trainees attend a Grant Writing Workshop, where they develop skills to enable them to successfully
apply for future grant funding. Training of scholars is guided by Individualized Development Plans and iterative
Program Evaluation. The program is committed to promoting diversity in biomedical sciences and, in the past
funding cycle, four of fourteen pre- and post-doctoral trainees and four of twenty one medical students were from
historically marginalized backgrounds. By training pre-doctoral students, post-doctoral fellows, and medical
students in an environment and culture that provides strong multi-disciplinary support for diabetes research and
an appreciation of diversity, equity, inclusion, and justice, this program will educate trainees who have a
sustained interest in diabetes and who will contribute significantly to the field. The Indiana University School of
Medicine is an outstanding forum for such an initiative, as the School has strong traditions in diabetes research
and patient care, as well as comprehensive research training. This program will continue to meet a critical need
by recruiting, mentoring, and training a talented and diverse cadre of scientists who are poised to carry out
cutting-edge basic science and translational research focused on improving the health of individuals with or at
risk of type 1 and type 2 diabetes, obesity, and their associated complications.
Project Summary/Abstract Page 6

Public health relevance
Contact PD/PI: WEK, RONALD C PROJECT NARRATIVE Metabolic diseases, including diabetes mellitus and obesity, are major public health concerns in the US and worldwide. The objective of this Training Program is to recruit, mentor, and train a talented and diverse cadre of scientists to carry out cutting-edge basic science and translational research focused on improving the health of individuals with or at risk of type 1 and type 2 diabetes, obesity, and their associated complications. This program will leverage the infrastructure, resources, and rich training environment of the Indiana University School of Medicine and the Indiana Diabetes Research Center to nurture the careers of the next generation of diabetes, obesity, and metabolism investigators. Project Narrative Page 7